Development of the MasSpec Pen Technology for Rapid and Accurate Identification of Pediatric Infections

ABSTRACT: Osteoarticular infections (OAI) are prevalent medical conditions that disproportionately affect children,
which can lead to serious complications including loss of motor function and bone deformity. Rapid and accurate diagnosis
of OAI etiologic agents are critical to allow selection of specific and targeted treatment options and improve outcomes for
pediatric patients. Yet, in clinical practice, patients are often started on broad spectrum antibiotics pending pathogen
identification by culture or polymerase chain reaction, which can take several days for completion. In addition, the high
rates of culture-negative OAI and the increased prevalence of antibiotic resistant strains make therapeutic decisions uniquely
challenging for OAI. Meanwhile, unspecific therapy regimens with multiple antibiotics can lead to multiple short- and long-
term adverse effects. Here, we propose to develop and test the MasSpec Pen (MSPen) technology as an innovative method
for rapid and accurate identification of OAI directly from clinical specimens. We developed the MSPen as an easy-to-use
handheld device integrated to a high-performance mass spectrometer for rapid (<20 seconds) detection of rich metabolic
profiles directly from biological samples. Now, we hypothesize that the MSPen can be developed as a powerful technology
for rapid, direct, and accurate identification of etiologic agents from OAI clinical samples, thus advancing treatment for
pediatric patients by allowing selection of specific and targeted therapy. Through a collaboration between Prof. Livia S.
Eberlin (Department of Chemistry, The University of Texas at Austin), expert in mass spectrometry and developer of the
MSPen technology, Dr. Sarmistha B. Hauger (Chief of Pediatric Infectious Disease, Dell Medical School) and Dr. Lindsey
Kirkpatrick (Infectious Disease Faculty, Indiana University School of Medicine), whose medical practices are dedicated to
the treatment of pediatric infections, we propose to test our hypothesis by carrying out the following specific aims:
Aim 1. Optimize the MSPen assay for molecular analysis of pediatric OAI clinical specimens and associated culture
isolates. The MSPen provides transformative molecular detection capabilities in the direct analysis of complex biological
samples along with operational features that are attractive for routine clinical use. We will refine the device and method to
optimize its analytical performance for direct molecular analysis of OAI clinical specimens and corresponding culture
isolates. Aim 2. Determine the diagnostic performance of the MSPen for pathogen identification in pediatric OAI
samples. The MSPen has the potential to provide molecular information to drive rapid and accurate therapeutic decision-
making. We will analyze pediatric OAI samples prospectively collected for our study encompassing clinically-relevant
bacteria strains. Statistical classifiers will be developed to classify bacterial pathogens into taxonomical levels using clinical
microbiology results as gold-standard. Aim 3. Evaluate the capabilities of the MSPen for the identification of antibiotic
resistant bacterial strains. The increasing occurrence of antibiotic resistant bacteria in pediatric patients presenting OAI
reveals a critical need for accurate identification of antibiotic susceptibility. We will investigate the capability of the MSPen
in identifying antibiotic resistant and susceptible bacteria in clinical samples. Statistical classifiers will be developed to
identify resistant or susceptible S. aureus, using clinical microbiology results as gold-standard.

Public health relevance
Narrative Osteoarticular infections (OAIs) of bones and joints are a common medical condition disproportionately affecting children which, when improperly treated, can lead to sepsis, joint destruction, growth failure, chronic infection, and even death. Rapid selection of a targeted antibiotic against the specific bacteria causing the infection is critical to effectively treat pediatric patients suffering from OAI, yet current methods used in clinical practice to identify bacteria can take days to complete and often yield insufficient results. In this project, we propose to develop an innovative technology called the MasSpec Pen as a new method for rapid and accurate identification of OAI bacteria directly from clinical specimens, with the expectation that the acquired metabolic information can be used to rapidly (in seconds) identify the bacteria causing the infection, leading to improved treatment decisions and outcomes for pediatric patients.